Molecular Biology of Viral Diseases Predoctoral Training Grant

Project Summary/Abstract
Over the past several decades, the world has experienced a surge in outbreaks of virus-induced disease that
have led to significant human suffering, while putting considerable stress on the global public health system and
society. Due to the scientific and public health challenges posed by these viruses, there is an ongoing need for
well-trained virology researchers. To meet this need, the UNC predoctoral T32 Virology Training Program
requests support for 5 training slots per year. The UNC Virology Training Program consists of 22 faculty
members whose research focuses on a diverse set of RNA, DNA, and retroviruses. Together the UNC virology
faculty provide cutting edge virology training in viral pathogenesis, virus-host interactions, model systems, host
genetics of virus susceptibility, antiviral and vaccine development, carcinogenic mechanisms, as well as
translational research opportunities focused on a number of important human pathogens. Our Program provides
our students with fundamental training in virology, combined with laboratory-based training in state-of-the-art
virology techniques, while developing critical thinking and scientific communication skills. Our goal is to develop
our trainees into well-rounded scientists that are positioned to successfully pursue scientific careers in virology-
related research. To achieve these goals, our students receive one to two years of support from the Training
Grant during years 3-5 of their training. Our students take three one semester courses covering molecular
virology, viral pathogenesis, and a special topics course focused the virology literature. Students routinely
present their research at multiple in-house seminar series, take part in several virology focused mini-
symposia/training activities, and present their work at local, national, and international scientific meetings. We
provide students with a broad array of career development activities in the form of small group meetings, career
panels, as well as internship and training programs. In this renewal, we have continued our established
Responsible Conduct of Research (RCR) training, expand student training in Scientific Rigor, provide students
with additional career development activities, and build on our already strong dedication to promoting diversity
and equity within the scientific community. Our program has an outstanding track record of successfully training
virologists, and our trainees routinely go on to perform postdoctoral training in top notch research laboratories
and have long term success in academic, industry, and government research positions. Therefore, support for
the UNC Virology Training Program will allow us to meet a pressing need by allowing us to continue to train the
next generation of outstanding virology researchers.

Public health relevance
Project Narrative Virus-induced diseases represent a significant ongoing threat to human health, and the fight against these viruses requires a well-trained virology workforce. To meet this need, we are proposing the renewal of the UNC-Chapel Hill Virology T32 Program, which provides our pre-doctoral trainees with outstanding training in fundamental virology, while providing them with world-class research training focused on a diverse set of RNA viruses, DNA viruses, or retroviruses.